Toll Like Receptors in Bacterial Keratitis

DESCRIPTION (provided by applicant): Corneal infections caused by the Gram positive bacterial Staphylococcus aureus (Staph) and Streptococcus pneumoniae (Strep) occur in the USA and worldwide, causing painful, sight-threatening disease. Further, methicillin resistant S. aureus (MRSA) are becoming more common, as MRSA are more difficult to treat and are more virulent than methicillin sensitive strains. The Aims of this proposal will focus on the role of IL1ß in S. aureus and S. pneumoniae keratitis because our preliminary data show that this cytokine has a critical role in regulating corneal infection by either bacteria. IL-1ß secretion requires tw signals - Signal 1 for transcription, and Signal 2 for enzymatic processing; therefore, Aim 1 will examine the role of bacterial cell wall in inducing NOD2/RIP2 signaling in IL-1ß-/- transcription, and Aim 2 will examine the role of Staph aureus α-hemolysin and Strep pneumoniae pneumolysin induction of the NLRP3/ASC inflammasome in caspase-1 mediated IL-1ß cleavage. Aim 3 will examine the role of ATP and purinergic receptors in amplifying inflammasome activity and IL-1ß production. Results of these studies will identify novel pathways that can be targeted for anti-inflammatory therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE: Bacterial infections of the cornea are a cause of painful, sight-threatening disease in the USA and worldwide. Further, methicillin resistant Staphylococcus aureus (MRSA) are becoming more common and are more difficult to treat. In addition, Streptococcus pneumoniae is a major cause of keratitis in developing countries. The Aims of this proposal will focus on the role of an inflammatory cytokine - IL-1ß - which has an important role in regulating corneal disease due to either bacteria. Experiments described in the proposed study will examine the role of virulence factors (toxins) from these bacteria in host cell signalin and IL-1ß production in the cornea with the goal of identifying novel, targeted anti-inflammatory therapy that can be used for treatment during corneal infection.